Subproject on research involving HIV/AIDS

The goal of this project is to provide support of National Toxicology Program (NTP) activities targeted toward the prevention of diseases or adverse effects caused by exposure to chemical or physical agents. Toxicity testing is an important aspect of public health research in that it serves to identify chemicals that are hazardous to human health. This program is designed to evaluate toxicity following early life exposure to chemicals.